Project 1: Sex-specific developmental epigenetics in gliomagenesis

PROJECT SUMMARY
Glioblastoma (GBM) is the most devastating form of brain cancer. In the next year, approximately 22,000
Americans will develop GBM and nearly the same number will die from it. While GBM occurs in both males and
females, we can reliably predict that of the 22,000 new cases, 8,500 will be in females while the remaining 13,500
cases will be in males. Moreover, while the median survival for female GBM patients next year is expected to be
approximately 22 months, for males it will be closer to 16 months. The molecular bases for these consistent and
significant sex differences in incidence and survival are unexplained. In the absence of an explanation, it is
impossible to fully know what the implications are for modeling GBM in the laboratory and for treating GBM in
the clinic. Defining the genetic and epigenetic mechanisms that underlie sex differences in GBM
incidence and survival is the focus of this project. We recently published an analysis of GBM patient imaging,
transcriptomes, and survival in which we determined that female GBM patients exhibit greater response to the
current standard treatments and that their survival is highly correlated with expression of components of the
integrin signaling pathway. In contrast, male GBM patients exhibit less robust response to current treatment and
their survival appears to be more potently determined by expression levels of the cell cycle regulatory machinery.
These data not only provide new insights into sex differences in GBM biology, they suggest that sex-specific
targeting of pathways that support survival in females and males could lead to improved outcomes for all patients.
Sex differences in health and disease accrue throughout life as a consequence of sexual differentiation. Sexual
differentiation, which begins at the time of fertilization, involves genetic and epigenetic mechanisms, as well as
the acute actions of circulating sex hormones. We have developed murine models for studying sex differences
in GBM. Here, we will use our innovative Cas-9 adaptation of the established four-core genotypes model for
measuring the distinct contributions of sex chromosome complement and gonadal secretions to sex differences
in GBM biology. Coupled with in utero electroporation of gRNAs and other genetic constructs, we will be uniquely
positioned to assess how sex-specific changes in chromatin structure and expression of specific genes mediate
the sex differences in GBM. We have two aims to address the hypothesis that sex differences in GBM incidence
and outcome are determined at early stages of in utero sexual differentiation (Aim 1) and involve sex-specific
patterning in gene expression and activity in integrin and cell cycle regulatory pathways (Aim 2). At all stages of
this work we will incorporate specific questions about sexual differentiation and iron metabolism (Project 2) and
microglia function (Project 3). Together these studies will provide critical information in our effort to understand
the molecular basis for sex differences in GBM and a path for the implementation of sex-specific treatment for
GBM and other cancers that exhibit sex differences in incidence and outcome.

Public health relevance
Project Narrative Glioblastoma (GBM) is the most devastating form of brain cancer and like many other cancers, females are less likely than males to develop GBM, and, in both children and adults with GBM, outliers for longer survival are predominantly female. In recently published work, we identified integrin signaling and cell cycle regulation as determinants of survival in female and male GBM patients, respectively. We predict that understanding how specific molecular pathways contribute to sex differences in GBM, will reveal novel sex-specific therapeutic targets that will serve as the foundation for improving survival for all GBM patients through the implementation of sex-specific approaches to treatment. !